ALTACE IN NORMAL WEIGHT AND OBESE PTS WITH HYPERTENSION

The purpose of this study is to evaluate the antihypertensive effects of Altace in normal weight and obese patients with mild to moderate hypertension.